Genome-wide Pleiotropy Scan across Multiple Cancers

Project Summary Cancer is a common but complex disease with a number of unresolved issues surrounding its underlying genetic basis. Recent work suggests that some phenotypically distinct cancers may arise due to similar genetic factors. We propose to evaluate this potential pleiotropy using existing genetic measures in the large, well-characterized Kaiser Permanente Research Program in Genes, Environment and Health cohort. This cohort includes over 110,266 individuals with a genome-wide array data, and 22,575 of these individuals will have been diagnosed with cancer by the start of this project. We will leverage this information to undertake a comprehensive evaluation of the shared genetic basis underlying cancers. In particular, our initial aim will evaluate the heritability and overall shared genetic basis of different cancers sites. Then we will investigate whether specific genetic variants impact risk of different cancers, incorporating into our analyses information about cancer organ systems and exposures that may modify the genetic associations (e.g., smoking). Our third aim will decipher the genetic basis of multiple cancers occurring in the same individual, including exome sequencing of the approximately 1,800 individuals diagnosed with multiple cancers in the cohort and their family members as available. Based on our findings from these aims, we will evaluate the potential biological and functional relevance of genetic variants exhibiting carcinogenic pleiotropy. Taken together, this project provides a unique, innovative, and efficient opportunity to detect pleotropic associations across a range of cancer sites in a single, large cohort. he individual-level data from an essentially population-based study allows us to evaluate novel hypotheses about the shared genetic basis of multiple cancers, and nicely complements existing meta-analyses efforts across different GWAS of the most common cancer sites. Understanding such potential carcinogenic pleiotropy may help clarify the biological basis of this disease, explain and predict the occurrence of multiple cancers, and insights into possible treatment strategies among patients with seemingly distinct cancers.

Public health relevance
Project Narrative Growing evidence suggests that the same genetic risk factors may impact risk of multiple different cancers. We aim to investigate this by studying the co-inheritance and shared genetic basis of a large number of cancers from a single, large population. Results from this project could help clarify the biological basis of the carcinogenic process, distinguish genes responsible for increased risks of second cancers, and identify potential drug targets and treatments that may work across different cancers.